Uncovering the transcription factors that control human motor neuron cell fate

PROJECT SUMMARY
To generate all the cell types that comprise the human body, pluripotent cells transition through various
identities before reaching their terminal cell fates by relying on a tightly regulated series of gene expression
profiles regulated by transcription factors (TFs). A comprehensive understanding of the critical regulator TFs
driving cellular differentiation processes will facilitate the study of human developmental disorders and the
generation of clinically relevant cell types for disease modeling and regeneration.
Motor neurons (MNs) from the ventral spinal cord are a clinically relevant cell type and a classic neuronal
developmental model. MNs are efferent neurons that act in circuits to innervate muscles, and impairment of
MNs leads to muscle atrophy and eventual loss of motor function. MNs are the primary cell type implicated in
spinal muscular atrophy (SMA), a developmental disorder, and amyotrophic lateral sclerosis (ALS), a
neurodegenerative disease, both of which affect nearly 1 in 10,000 people. Currently, the only available
treatments for these diseases are supportive. Thus, my proposal aims to enhance our understanding of MN
differentiation.
The human genome codes for over 1600 TFs, but only about 50 TFs are known to be important during human
spinal cord development. Recent scRNA-seq analyses reveal that more than 800 TFs are differentially
transcribed during this developmental process, suggesting that the field has under-sampled the TF landscape.
As an unbiased approach to identify important TFs for differentiation processes, two CRISPR screens have
uncovered previously unknown TFs important for neuronal cell fates. Using a simple, TF-directed neuronal
differentiation system, the first screen revealed that ZBTB18, a C2H2 zinc finger repressor that binds E-box
motifs, is critical for neuronal fate downstream of NEUROG2. In humans, Zbtb18 mutations are associated with
nervous system developmental defects. ZBTB18 has also been predicted to be critical for the generation of
spinal cord MNs. Using a small molecule-directed MN differentiation method in mouse embryonic stem cells,
the second, unpublished screen revealed 69 new TF candidates essential for progression through the stages
of the MN differentiation process. This proposal aims to further characterize the TFs from these two screens by
addressing the following questions:
1. What is the role of ZBTB18 in human MN differentiation?
2. Which TFs identified by the mouse screen have conserved functions in human MN differentiation?
The completion of this proposal will uncover a more complete gene regulatory network controlling human MN
differentiation.

Public health relevance
PROJECT NARRATIVE Transcription factors are vital regulators of cell fate, controlling gene expression by establishing cell type- specific gene regulatory networks. This project aims to expand our understanding of human development by identifying and characterizing key transcription factors required for human motor neuron differentiation. This proposal will reveal a more complete gene regulatory network guiding one human differentiation trajectory and establish a framework for characterizing transcription factors important for any differentiation trajectory, providing new insights into human developmental disorders and facilitating the generation of disease-relevant cell types.